Creation of a Schwann Cell Gene Regulatory Network

Abstract. The peripheral neuropathy known as Charcot-Marie-Tooth Disease (CMT1A)
is one of the most common heritable disorders in the nervous system, affecting 1 in
2500 individuals. Tremendous progress has been made in identifying structural and
coding variants that cause this disease, with over 100 genes having mutations
associated with CMT. However, a substantial number of individuals do not have a
definitive genetic diagnosis. The goal of this project is to develop a comprehensive
Schwann cell gene regulatory network model incorporating experimental data on
peripheral nerve with ChIP-seq analyses of TF binding as well as epigenomic
annotations from human peripheral nerve that have recently become available. The
model will incorporate data showing the dynamics of Schwann cell enhancers that have
been shown to become dynamically regulated after peripheral nerve injury. Moreover,
the model will be validated in its ability to identify key regulatory elements using eQTL
analysis. Development of a Schwann cell network model with sufficient resolution to
determine effects on individual enhancers and TF binding sites will be developed for
eventual application to WGS analysis of patient data with peripheral neuropathy,
including not only CMT but also other disorders affecting the peripheral nervous system.

Public health relevance
PROJECT NARRATIVE Formation of the myelin sheath that insulates nerves is critical for nervous system development, and disruptions of myelin cause peripheral neuropathy. One of the most common inherited disease of the nervous system, Charcot-Marie-Tooth disease, is most often caused by mutations of genes expressed in Schwann cells. This project will develop a computational Schwann cell Gene Regulatory Network to to help identify genomic variants that cause or modify human peripheral neuropathy.